Core A: Administrative Core

The purpose of Core A is to provide administrative support to the Program Leaders, to the Principal Investigators
of the Projects and Cores, and to the scientific personnel of the Projects and Cores of the Immune Perturbation
Study Group (IPSG). Core A will be located in Dr. Chung’s laboratory/office complex at the Liver Center and
Gastrointestinal Division of Massachusetts General Hospital. The main goals of Core A are to manage and
oversee the scientific efforts of the Projects and to coordinate scientific and administrative interactions. Thus,
the specific tasks of Core A will be: (a) to facilitate interactions between Program Investigators, Scientific Advisors
and administrative personnel, (b) to plan and coordinate the External Scientific Advisory Group (ESAG) meeting
as well as meetings between Program scientists, (c) to organize and coordinate travel for scientific advisors,
visiting scientists and Program Investigators, (d) to assist in the organization of the annual External Scientific
Advisory Group Meeting and Scientific Symposium, (e) to facilitate resource sharing including assisting in the
speedy execution of material transfer agreements (MTA) and (f) to assist the Program Directors and Principal
Investigators in preparation of progress reports, financial reports and manuscripts for publication. Core A will
also be responsible for the resolution of any potential conflicts.